Tennessee Occupational Health and Safety Surveillance Program

TN Occupational Health Surveillance Program
PAR-20-312
PROJECT SUMMARY
The Tennessee Occupational Health and Safety Surveillance Program’s (TN-OHSSP) goal is to
provide basic information about the risks faced by Tennessee workers that is fundamental for
effective policy and interventions. The program also provides more in-depth surveillance on
topics relevant to stakeholders.
The program looks to cultivate its nascent partnerships with such groups as the department of
labor, TOSHA, and safety groups, as well as groups within the Department of Health.
In service to its goals and its partners, TN-OHSSP endeavors to produce several reports:
- An annual Occupational Health Indicator report which conforms to standards set by the
Council of State and Territorial Epidemiologists (CSTE),
- An annual State of Worker Health report which reviews time trends for the OHI
indicators, and other related data points.
- A review of workplace related spread of COVID-19 in TN
- Special topic reports on the underserved high-mortality risk occupations, and requests
from partners, such as causes of work-related hospitalizations.
In addition to developing reports, the program works to improve the available data and
indicators. The program advocates for health data sets to collect occupational data. Under this
project, TN-OHSSP is working closely with the team that gathers laboratory reports of blood
lead levels to gather occupational data for individuals with elevated blood lead levels.

Public health relevance
TN Occupational Health Surveillance Program PAR-20-312 PROJECT NARRATIVE (limit 3 sentences) The Tennessee Occupational Health and Safety Surveillance Program provides fundamental information about the occurrence of work-related injuries and illness. By doing so the program aims to guide policy, affect research, and help interventions, in order to improve the health and safety of Tennessee workers.